Cortical interneuron subtypes adapt to signals from local pyramidal cells

PROJECT SUMMARY
The incredible ability of the cerebral cortex to perform sophisticated computation, integration, and cognition relies
on the intricate building of its complex neuronal architecture. The cerebral cortex primarily consists of densely
packed excitatory neurons that are embellished with a small set of local inhibitory interneurons. Despite the small
number, cortical interneurons have astonishing diversity in their transcriptome, morphology, electrophysiological
property, and connectivity. A long-standing question is to understand how and why the diversity among cortical
interneurons is generated and needed. The goal of the proposal is to understand how the subtypes of cortical
interneurons adapt to the molecular identity of the excitatory neurons to which they pair to form specialized local
microcircuits. The central hypothesis of this proposal is that distinct subtypes of cortical interneurons partner with
different types of excitatory neurons. In other words, the composition and molecular identity of excitatory neurons
in different cortical regions govern the distribution and composition of cortical interneuron subtypes. The specific
aims will approach this hypothesis from two different angles. Using somatostatin-expressing cortical interneurons
as an example, In Aim 1 I use mouse genetic tools to target different transcriptomic subtypes of deep-layer
somatostatin interneurons to investigate their laminar distribution, morphology, and stereotyped local
microcircuitry. I will use both anatomical and functional measures to demonstrate the selective connectivity
towards different pyramidal neuron subtypes. In Aim 2, I utilize mutant mice in which the molecular identities of
a subset of excitatory neurons are altered. Using single-cell RNA sequencing of cortical interneurons, in
combination with in situ hybridization against marker genes for different somatostatin interneurons, I will
investigate the effects of altering excitatory neuron identity on the composition and identity of local interneurons.
Finally, in Aim 2 I test whether pyramidal neurons govern the survival of interneuron subtypes or guide
interneurons to specific subtypes through extrinsic cues. Substantial preliminary results are presented in the
research plan supporting the significance and feasibility of this proposal. The long-term objective of this work is
to identify the molecular mechanisms underlying the lock-and-key mechanisms between subtypes of excitatory
neurons and interneurons.
This fellowship will support the next stage of training in my path towards becoming an independent
neuroscientist. I aim to integrate the molecular neuroscience experimental techniques acquired during this
training period to my previous electrophysiological technical background, which will enable me to answer
scientific questions with multiple approaches. My long-term career goal is to conduct basic scientific research
that will advance our understanding of the wiring and function of the brain.

Public health relevance
PROJECTIVE NARRATIVE This proposal investigates how the identity of pyramidal neurons governs the distribution and composition of diverse subtypes of interneurons by testing the idea that a lock-and-key relationship exists between specific subtypes of inhibitory interneurons and certain types of pyramidal neurons. This work aims to understand how diverse subtypes of interneurons find their niche after a long migration and establish themselves within specialized local microcircuits. This study will contribute fundamental knowledge about the organizational principles of the intricate cortical circuits, which is necessary for understanding the pathophysiology of various neurological diseases in which the wiring of the brain is altered during development.